The impact of sepsis-induced inflammation on pancreatic cancer liver metastasis

1 PROJECT SUMMARY
2 Pancreatic ductal adenocarcinoma (PDAC) is a highly metastatic malignancy and the third-leading cause of
3 cancer-related death in adults. A majority of patients who undergo surgery for primary PDAC resection will later
4 develop lethal metastases, despite intra-operative examination confirming the absence of macrometastatic
5 lesions. Liver metastases constitute nearly half of recurrences detected within six months after PDAC resection,
6 which is significantly earlier in the postoperative period compared to other metastatic sites. Several clinical and
7 experimental studies have shown that perioperative inflammation, including infectious complications like sepsis,
8 can promote liver metastasis. This is intriguing because bacterial-derived endotoxin is elevated in PDAC patient
9 plasma during tumor resection. Furthermore, PDAC patients are at increased risk of developing sepsis, which
10 suggests that tumor-systemic communication in part rewires systemic immunity and, consequently, sepsis
11 susceptibility. Despite these observations, we currently lack mechanistic studies investigating the relationship
12 between perioperative inflammation and PDAC liver metastasis. The overarching objective of this project is to
13 determine how pro-metastatic immune responses can be suppressed to protect against liver metastasis during
14 PDAC resection and sepsis-induced inflammation. To define how sepsis-induced inflammation impacts the liver
15 immune microenvironment, I first modeled the perioperative inflammation that PDAC patients may experience
16 during surgery by using the lipopolysaccharide (LPS) model of sterile endotoxemia, and the more clinically
17 relevant cecal and ligation puncture (CLP) model of polymicrobial sepsis. My preliminary data demonstrates that
18 performing CLP prior to seeding PDAC cells in the liver had a pro-metastatic effect. However, LPS challenge
19 had an anti-metastatic effect marked by increased CXCL9 and CXCL10 release and natural killer cell infiltration
20 in the liver during early sepsis response. Therefore, this approach presents an exciting opportunity to define how
21 LPS-induced sepsis elicits an anti-metastatic cascade to reduce liver metastasis. The central hypothesis of this
22 project is that determining how sepsis-induced immune responses influence liver metastasis will reveal critical
23 mechanisms that can be targeted to create a protective ‘anti-metastatic niche’. To test this hypothesis, Aim 1 will
24 elucidate the anti-metastatic signaling mechanisms underpinning LPS-induced sepsis, and uncover potential
25 therapeutic targets that can be exploited to reduce PDAC liver metastasis. Aim 2 will examine the therapeutic
26 potential of targeting pro-metastatic inflammation during sepsis by evaluating how the quality of sepsis-induced
27 immune responses are impacted by systemic immunosuppression, which is a well-established hallmark of
28 PDAC. The findings of these experiments will uncover critical regulators of perioperative inflammation and
29 systemic immunosuppression in PDAC, and set the stage for the development of preventative therapies to
30 reduce the incidence of liver metastasis among resected PDAC patients.

Public health relevance
NARRATIVE Approximately 75% of pancreatic cancer patients who undergo primary tumor resection will develop metastases, and nearly 50% of early postoperative metastases will occur in the liver. We discovered that inflammation from infectious complications during surgery, like sepsis, can influence the ability of pancreatic cancer cells to form liver metastases. In this project, I will determine how sepsis impacts the liver to uncover new therapeutic targets that can block the tumor-promoting effects of perioperative inflammation in order to reduce liver metastasis among resected pancreatic cancer patients.